SPECT IMAGING IN SUBJECTS WITH BORDERZONE COGNITIVE IMPAIRMENT

The purpose of the study is to use Single Photon Emission computed Tomographic (SPECT) as an objective marker of brain pathology, in order to examine characteristics of diagnostic criteria used in dementing conditions.